Environmental chemical mixtures and metabolomics in autism spectrum disorder

Abstract
Autism spectrum disorder (ASD) is a heterogeneous disease with an unknown etiology. The global increase in
ASD incidence suggests that genetics alone is unlikely to be the major driver of ASD, but that the increased
prevalence is likely due to altered exposures to environmental factors. In fact, we know that numerous
environmental exposures (nutrients, chemicals, stress, etc.) impact child health, typically exerting their toxicity
through either metabolites or perturbations in endogenous pathways, making metabolomics analysis a key
emerging technology to elucidate the relationships between these exposures and ASD. But how do we directly
measure these early life exposures? Central to our study is the use of novel tooth matrix biomarkers, which
takes advantage of the incremental developmental biology of teeth (similar to tree growth rings). The
techniques that we have developed allow us to temporally distinguish exposure between the 2nd trimester, 3rd
trimesters, and postnatal periods, enabling identification of the sensitive life stages in fetal and neonatal
development most strongly associated with ASD risk. For the present application, we will perform the first
targeted organic analysis of ASD teeth to delineate associations between toxicant mixtures from various
exposure sources (polybrominated diphenyl ethers (PBDEs), phthalates, and organochlorine pesticides) and
autism. This will be supported by the first large-scale untargeted metabolomics analysis of ASD teeth to
delineate unique metabolic alterations in corresponding autism and non-autism children, and generate new
hypothesis on early life etiology of ASD. As both analyses will be executed in the same tooth extract, we will
also perform a multifactorial analysis, exploring the relationships between targeted toxicant exposures,
metabolomics profiles, and ASD. We will undertake this work in the Childhood Autism Risks from Genetics and
the Environment (CHARGE) cohort, which has a wealth of harmonized phenotypic, demographic, medical,
genetic, and environmental data for high efficiency analysis. We will use novel statistical methodology,
weighted quantile sum regression (WQS), that addresses effects of high-dimensional mixtures and increases
power when compared to traditional methods to discover biomarkers and biological pathways associated with
ASD (n=318) or typical development (n=190) (neither ASD nor other developmental delays (n=105)). Our
method is a non-invasive advancement in technology to obtain direct and repeated fetal measures of
biomarkers associated with early life etiology of ASD.

Public health relevance
Project Narrative: The studies proposed here are relevant to public health for three reasons. First, they will allow us to identify individual and organic toxicant mixtures associated with ASD prior to the onset of clinical signs, as possible causal agents. Second, they will allow the discovery of exogenous and endogenous metabolites, and biological responses associated with ASD prior to the onset of clinical signs, so that we can objectively identify potential causal pathways and markers that can serve as the foundation for treatment strategies. Third, the temporal resolution afforded by the novel tooth biomarker technology allows us to identify the sensitive life stages for metabolic perturbations and toxicant exposures in fetal and neonatal development most strongly associated with ASD risk.